Children's Tumor Foundation 2014 Neurofibromatosis (NF) Conference

DESCRIPTION (provided by applicant): The Neurofibromatosis (NF) Conference This meeting organized by the Children's Tumor Foundation is recognized as the premier annual gathering of international NF researchers and physicians. Major contributors to this growth are the significant advances made in NF research in recent years and, particularly, recent advances into clinical trials and drug therapy development, which have been fostered by the collaborations established at this very event. Children's Tumor Foundation: 2014 NF Conference Yuan Zhu, Ph.D., Principal Investigator

Public health relevance
PUBLIC HEALTH RELEVANCE: The Children's Tumor Foundation NF Conference has a remarkable presence in the neurofibromatosis community. It plays a lynchpin role in accelerating neurofibromatosis research and collaboration. The Conference provides a forum for research information exchange and discussion for neurofibromatosis researchers and clinicians from around the world. Children's Tumor Foundation: 2014 NF Conference Yuan Zu, Ph.D., Principal Investigator